256-channel Digital Neural Signal Processor Real-Time Data Acquisition System

Project Summary/Abstract:
Understanding the human brain’s astounding functions and profoundly disabling dysfunctions, from the level of
the single cell to the span of the entire cerebrum, is the primary focus of 21st-century neuroscience. Historically,
revealing the complex mechanisms underlying the function, and dysfunction, of the brain has relied primarily
on non-human animal models. Advances in materials science, computational analytics, surgical approaches,
and neurophysiology now enable recordings from hundreds to thousands of contacts in the human brain for
research purposes. Furthermore, in the last 15 years, specialized microelectrode recording systems to record
from the human brain as well as modulate its activity have been increasingly used in clinical settings.
Unfortunately, the equipment to acquire and faithfully record this rare and precious data is costly and requires
considerable technical expertise to maintain and operate. These hurdles can be mitigated by the fact that
multiple laboratories can share such equipment to pursue highly significant essential neuroscientific questions
in parallel.
Team members on this application have used human intracranial recordings to make discoveries in many
areas of neuroscience. Leaders in the field of human neurophysiology, the groups represented by this
extensive list of studies have worked collaboratively for years as well as carried out independent parallel
studies on human brain function. However, current systems used by these groups are becoming obsolete and
lack the capability of recording from the latest high-count electrodes. These devices and the next generation
recording system represents the next step in answering key human neuroscientific questions regarding
cognition, language, anesthesia, sleep, seizure activity, neuromodulation, and tumor infiltration. Acquiring the
latest, cutting-edge recording and stimulation system for high channel count intracranial recordings capable of
single brain cell human recordings will allow a local consortium of highly productive human neuroscientific
users to expand the reach of this group’s basic and translational scientific efforts. This team approach,
centered on extraordinary human neurophysiological recording equipment that is shared across multiple
research projects, is critical for accelerating novel therapies for a wide range of neurological and
neuropsychiatric challenges.

Public health relevance
Project Narrative Truly understanding the human brain in health and disease requires a detailed examination of neuronal activity at the scale of small populations of neurons and even individual cells. Technological advances have made it possible to record from 100s of areas and 100s of neurons in the human brain. This shared instrument request looks to acquire the latest, cutting-edge electrophysiologic recording system approved for human use to share by a multidisciplinary, highly collaborative, and cross-institutional group of researchers.